Colorado Women's Reproductive Health Research Career Development Center

PROJECT SUMMARY
The Colorado Womens Reproductive Health Research Career Development Program (‘Colorado WRHR’) hereby seeks its 6th funding cycle. Our outstanding team of 27 mentors, includes 5 past WRHR primary mentors, and 14 past or current K12 Scholar mentors, the PI and Research Directors Raj Kumar, PhD and Jeanelle Sheeder, PhD. Our research theme broadly emphasizes Womens Reproductive Health at key life transitions: 1. Reproductive Aging, Cardiometabolic Fitness, and Brain Health; 2. Maternal Health and Reproductive Life Course; and 3. The Immune System and Its Links to Gynecologic Cancer. Each window of research opportunity will also include cross cutting themes incorporating Social Determinants of Health and Artificial Intelligence whenever possible. Specific Aims follow:
Aim 1: Design the most effective training program for early career physician scientists in OBGYN in the nation. We will employ best practices and thoughtfully applythe recommendations from our Advisory Committees. We will provide the fundamentals that have served our scholars well in the past and will continue to incorporate feedback from program graduates and engage past Scholars in our program who are no longer at the University of Colorado through research retreats and collaborations.
Aim 2. Prepare Scholars for leadership and advocacy in Women’s Reproductive Health Research. We will promote skill development in leadership and advocacy through trainings available locally at the institutional level and nationally such as the AAMC Early Career Development program. We will continue to model advocacy for Women’s Health Research through the efforts of the PI (past co-Chair of the Women First Research Coalition), RDs and mentors, and our professional organizations.
These aims are designed to meet and exceed the goals the of RFA-HD-25-005 to create the next generation of leaders in our field.

Public health relevance
RELEVANCE This proposal plans to provide an unparallelled training opportunity for early career physician scientists in Obstetrics and Gynecology. Scholars will be selected from a national pool and undergo an intensively supervised mentored research training experience designed to propel them to an independent career in research in Women’s Reproductive Health.